Role of IFITs in RBC Alloimmunization

Approximately 1 out of every 70 people (~5,000,000 patients) are transfused each year in the USA alone. Over
340 red blood cell (RBC) alloantigens have been identified in addition to the well-known ABO and RhD antigens.
Over time, some patients generate antibody responses against so many RBC alloantigens that compatible RBC
units become increasingly difficult to identify, and in some cases are unavailable. This leads to considerable
morbidity and in extreme cases mortality. Despite the large number of alloantigens, only a minority of patients
ever become alloimmunized (~2-5%). This remains very significant given the number of people transfused each
year and leads to the question of why certain people become alloimmunized and others do not. Moreover,
patients tend to be either “responders” with a relatively high frequency of alloimmunization or
“nonresponders” with no detectable alloantibodies even after chronic transfusion. Responder vs.
nonresponder status has been shown to have both environmental and genetic components. Viral infection with
RNA viruses at the time of transfusion is associated with RBC alloimmunization in both mice and humans and
has been shown to cause alloimmunization in mice by inducing interferon-alpha and signaling through the
interferon-alpha/beta receptor (IFNAR). Preliminary data presented in this grant demonstrate that murine
cytomegalovirus (mCMV) infection induces RBC alloimmunization through IFNAR independent pathways. Less
progress has been made in defining genetic factors that regulate responder vs. nonresponder status. A number
of genome wide association studies in humans have identified potential candidates, but running trials with
sufficient statistical power is challenging. In such cases, the use of animal models is a reasonable alternative.
We have reported that, much like in humans, there is substantial variability in genetics of responder vs
nonresponder biology across different strains of inbred mice. Using RBC alloimmunization as a trait, we
performed a GWAS study on 584 mice from a diversity outbred population and identified a region of chromosome
19 associated with alloimmunization (LOD score of 8.2, genome-wide p-value (0.036)). This region contains a
cluster of IFIT (IFIT1-IFIT3) genes (interferon-induced protein with tetratricopeptide repeats) that are interferon-
alpha response genes downstream of IFNAR signaling. Moreover, IFIT induction also occurs downstream of
mCMV infection. Thus, the two known pathways of RBC alloimmunization have IFIT induction as a common
distal event. Although best known for antiviral function, IFIT genes are increasingly being appreciated as being
immunoregulatory. Thus, multiple lines of evidence support the Central Hypothesis of this application: IFIT1
and IFIT2 suppress while IFIT3 enhances RBC alloimmunization. The current application proposes to use mice
with deletions of IFIT1, IFIT2, IFIT3 or the whole IFIT locus to test their causal roles in RBC alloimmunization.
The proposal is structured as a single Specific Aim, testing the role of each IFIT gene member individually, or
as a group, in RBC alloimmunization.

Public health relevance
Approximately 1 in every 70 people are transfused each year. Over time, the immune system of patients can recognize donor blood as foreign, making it harder and harder to find units of blood that can be transfused. This project attempts to understand how transfusion recipients respond to donor blood to help guide the development of ways to prevent this problem.